Engineering for Women's Health

The Engineering for Women’s Health Conference addresses historical disparities in women’s health
research by establishing a dedicated platform for interdisciplinary collaboration and discourse.
Despite the historical emergence of gynecology, progress in women-specific health issues has
experienced a notable lag. This conference, situated in Greater Boston, a nexus of cutting-edge
institutions, emphasizes the crucial role of engineering in advancing women’s health. Specific Aim 1
focuses on providing a platform for prominent engineering researchers and experts in women’s health
in the Greater Boston area to present and discuss their latest findings. This initiative aims to not only
foster collaboration and identify gaps in scientific knowledge but also underscore the pivotal
contributions of engineering to innovative solutions. Specific Aim 2 aims to engage the broader
community, particularly members in training, in a dialogue concerning the latest advancements in
women’s health research. Through traditional presentations, networking events, and the creation of a
publicly accessible “Conference Brief,” the project will extend the impact of collective efforts to a
broader audience, highlighting the importance of incorporating engineering perspectives in
addressing women’s health challenges. Aligned with the mission of the National Institute of Child
Health and Human Development (NICHD), this conference directly contributes to the improvement of
the health and well-being of women, underscoring the unique role that engineering can play in
enhancing health outcomes for women and children. Led by Principal Investigator (PI) Amini and
faculty co-advisor Bellini, the project involves a collaborative effort with a dedicated team of PhD
students. Distinguished speakers selected from the Greater Boston area will significantly contribute to
the overarching objectives of the conference. In essence, through the Engineering for Women’s
Health Conference the PI and the organizing team endeavor to bridge historical gaps, push the
boundaries and inspire innovation within the context of engineering, and contribute to the
advancement of health outcomes for women.

Public health relevance
The Engineering for Women’s Health Conference is relevant to public health as it addresses historical disparities in women’s health research, promoting interdisciplinary collaboration and innovation. By emphasizing the pivotal role of engineering principles, tools, and perspectives in advancing women's health, the conference contributes to the development of innovative solutions and practices that are expected to significantly improve the well-being of women. Ultimately, bridging historical gaps and inspiring innovation within the context of engineering directly aligns with national and local public health goals, aiming to enhance health outcomes and improve health-span for women across diverse communities.